SCISIPBIO: Examining the Career Barriers Confronting African American or Black Biomedical Scientists

Researchers have documented and attempted to explain differences in National Institutes of Health funding of African American or Black (AAorB) scientists (Ginther et al 2011, 2018; Hoppe et al 2019; Erosheva et al 2020; Lauer et al 2021). NIH reports that progress has been made (UNITE 2021), but a full account of career challenges faced by AAorB scientists has been hampered by lack of access to data on science faculty. This study will construct a dataset that identifies the race, gender, academic field, academic rank, publications, citations and grants of individual scientists by linking data on over 2 million individual faculty from Academic Analytics for the years 2009-2023, the NSF’s Survey of Earned Doctorates, NIH Reporter, the Integrated Postsecondary Education Data System, and web searches. These data will be used to examine race/ethnicity differences in the career paths of scientists at research-intensive universities. Aim 1 of this study will create the Demographic Academic Careers data set housed in a data enclave at National Center for Science and Engineering Statistics so the research community can make use of this rich data in other Science of Science research. Aim 2 will document the race/ethnicity distribution of faculty at 427 research-intensive universities and medical schools across the United States and their impact on students of color. This aim will examine whether institutions with more faculty of color produce more undergraduate and graduate students of color. Aim 3 will examine race/ethnicity differences in promotion to associate and full professor and the potential double-bind of gender and race/ethnicity. This aim will examine whether the race/ethnicity NIH funding gaps contribute to similar promotion gaps. Aim 4 will examine race/ethnicity differences in the age of research independence and funding longevity. Researchers have examined these topics in the aggregate or for women (Levitt & Levitt 2017; Hechtman et al 2018),yet the same has not been done by race/ethnicity. The longitudinal data developed in Aim 1 is ideal for this kind of study. Aim 5 will examine gender and race/ethnicity differences in NIH R01 renewals (Type 2) awards. Researchers have documented that women are less likely to receive Type 2 renewals (Ley and Hamilton 2008, Pohlhaus et al 2011). Ginther et al (2018) found that AAorB investigators were also at a disadvantage in renewals. This project will determine whether publications, citations, prior funding, and institutional affiliations explain these differences.

Public health relevance
his research is a necessary first step into crafting interventions to improve the career outcomes of AAorB faculty. Increasing the diversity of the biomedical workforce is essential to addressing the stubborn and persistent challenges of racial and ethnic health disparities. This research, like the previous work by Ginther et al (2011), will be used to develop policies that will lead to a more diverse biomedical workforce.